Novel Approaches to Identifying and Engaging Disadvantaged Patients with Alzheimer’s Disease (AD) in Clinical Research

PROJECT SUMMARY/ABSTRACT
Despite well-documented disparities in Alzheimer’s disease (AD) prevalence, incidence, diagnosis, treatment,
and mortality, individuals from disadvantaged backgrounds (e.g. racial/ethnic minorities) are disproportionately
under-represented in clinical AD research. Current recruitment methods for AD research predominantly identify
patients from outpatient clinics and community settings, or with pre-existing diagnoses. Reliance on these
recruitment approaches may create barriers to participation for disadvantaged individuals as they are more
likely to lack information about AD services, be undiagnosed and have limited access to outpatient care. Yet,
greater enrollment of disadvantaged individuals into AD studies is critically needed to achieve national goals for
AD research. Targeted AD screening and tailored recruitment within acute care settings has strong potential to
address these gaps, as disadvantaged individuals often rely on these settings to meet their health needs. This
K76 proposal is designed to provide Dr. Gilmore-Bykovskyi, PhD, a geriatric trained nurse and expert in AD
symptom management with the training required for success as an independent clinician-scientist focused on
improving AD identification to promote greater participation in research and access to effective care and
therapies, specifically targeting high-risk disadvantaged populations. The overarching objective of the
proposed research is to design screening and recruitment approaches for identifying and engaging
disadvantaged AD patients/caregivers and their biological children in research from acute care settings. The
proposal consists of validation of an electronic health record (EHR) Phenotype Model for AD using EHR
clinical data identified in preliminary studies (Aim 1), and specification of this Model for performance
among disadvantaged individuals (Aim 1a). To address recruitment from acute care environments, mixed
methods strategies will inform the design of tailored recruitment approaches appropriate to acute care
(Aim 2) which will be piloted with 30 AD patients/caregivers to determine their feasibility, acceptability
and preliminary impact on willingness to enroll in a Trial Registry (Aim 2a). As a junior faculty member at
an institution with extensive support for early stage investigators and significant infrastructure in AD disparities
and EHR Phenotyping, Dr. Gilmore-Bykovskyi is in an ideal environment to complete the proposed research
and pursue advanced training relevant to her career goals. Dr. Gilmore-Bykovskyi’s career development plan
integrates didactic and practical training, individual mentoring and mentored research activities in the areas of 1)
clinical trial design, 2) advanced statistical and machine learning techniques, 3) acute care research, 4) AD health
disparities, 5) recruitment and retention of vulnerable populations and 6) leadership. This proposed award
addresses fundamental gaps and barriers to improve inclusion of disadvantaged individuals in AD research
while affording training and mentored research critical for Dr. Gilmore-Bykovskyi to lead an independent
research program in clinical AD research.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Under-representation of individuals from disadvantaged backgrounds (e.g. racial and ethnic minorities) in Alzheimer's disease (AD) research is a major barrier to achieving national AD research goals and exacerbates widespread health disparities in AD. The proposed research addresses fundamental barriers to research participation among disadvantaged individuals with AD through the development of novel 1) screening and 2) recruitment approaches within acute care settings, where many disadvantaged individuals routinely seek health care. The long-term goal of the proposed research is to improve access and engagement in AD research among disadvantaged groups.